Gammaherpesvirus and IL-17: using host antibacterial defense to benefit chronic virus infection

Abstract
Gammaherpesviruses establish infection in >95% of adults and are associated with multiple cancers, including
B cell lymphomas. These viruses usurp B cell differentiation by infecting naïve B cells and driving entry of
latently infected and bystander B cells into a germinal center response to ultimately achieve life-long latency in
memory B cells. Importantly, the germinal center response is highly mutagenic and is thought to be the target
of viral transformation. The mechanisms by which gammaherpesviruses usurp B cell differentiation, including
germinal center response, are largely unknown. This proposal is based on our discovery that IL-17A
selectively promotes the gammaherpesvirus-driven germinal center response and viral reactivation, two
processes that are associated with increased risk of viral lymphomagenesis. IL-17A is induced by and
contributes to the clearance of bacterial and fungal pathogens, with our studies revealing an unexpected
proviral role of this cytokine. The proposed studies test the hypothesis that natural induction of IL-17A by
bacterial pathogens is usurped by gammaherpesviruses to promote germinal center response and
viral reactivation. The proposed studies will determine the extent to which a systemic or anatomically
restricted bacterial infection impacts gammaherpesvirus-driven germinal center response and viral reactivation
and use host and bacterial genetics to define the role of IL-17A in this process. Successful completion of the
proposed studies will for the first time define the impact of natural IL-17A induction by common bacterial
pathogens on the key pathogenic processes associated with viral lymphomagenesis and will provide insight
into novel approaches to target susceptibility to virus-driven lymphomas.

Public health relevance
Project Narrative Gammaherpesviruses infect over 95% of the human population and are associated with multiple cancers, particularly B cell lymphomas. IL-17A is a host cytokine that is expressed during fungal and bacterial infections and contributes to clearance of such infections. We discovered that IL-17A is usurped by gammaherpesvirus and promotes changes in the viral life cycle that are associated with virus-induced lymphomas. This proposal will determine how IL-17A, that is naturally induced by human bacterial pathogens, impacts the control of chronic gammaherpesvirus infection, including viral risk factors involved in virus-driven cancer.